National Pediatric Rehabilitation Resource Center: Pilot Studies

Project Summary (Pilot Studies)
We propose to sponsor a Pilot Studies program as a highly attractive incentive for investigators to engage with
our National Pediatric Rehabilitation Resource Center (PedRehab Ctr). The Pilot Studies program will place high
priority on encouraging innovation and funding pilot studies with high potential for discovering efficacious
treatments and promoting their rapid, high-fidelity, and effective application into clinical and community settings
(Implementation Science). We also will consider methods and techniques development research under the Pilot
Studies program, particularly when the topic fills a critical gap or seeks to overcome a major obstacle to
conducting high-quality medical rehabilitation research with pediatric populations. We will invest the maximum
amount allowed ($150,000 per year X 5 years = $750,000). We have proposed a partnership with the American
Academy for Cerebral Palsy and Developmental Medicine (AACPDM) to assist in announcing, reviewing, and
scoring the Pilot Studies, based on its current strategic plan, a strong process of peer review and tracking of pilot
study outcomes, and its role in working closely with NIH to establish and promote the use of the new Common
Data Elements for Cerebral Palsy. Final funding decisions will be made by the PedRehab Ctr team with input
and approval from the independent National Advisory Board.
Our specific aims for Pilot Studies are: 1) to work collaboratively to encourage the development of highly
promising ideas and methods that will benefit from critically needed Pilot Study data in order to obtain larger
scale NIH funding; 2) to offer direct assistance to investigators and interdisciplinary research teams as they plan
and finalize their proposals; 3) to provide timely funding for those applications judged the most meritorious; 4) to
lend post-award direct assistance (including activities within our PedRehab Ctr for Mentored Collaborative
Opportunities and Techniques Development) to those who receive funding with the goal of maximizing
successful completion and later use of results; and 5) to monitor the scientific findings generated by the Pilot
Studies and how these are used in subsequent research activities. In partnership with AACPDM, we will collect
evaluative data from the recipients about the impact of the Pilot Studies program. Overall, our proposed Pilot
Studies program includes embedded mentoring and collaboration – from pre-submission through post-award.